The transcriptional control of vascular calcification in disease

Cardiovascular diseases such as vascular calcification are a leading cause of death in patients with chronic
kidney disease (CKD). However, there is no effective therapy for vascular calcification available.
Phosphotoxicity and lipototoxicity are the major causes of CKD-dependent vascular calcification. Our long-term
goal is to identify new pharmacological strategies for the prevention of vascular calcification. Our previous
studies have demonstrated that stearic acid (C18:0), one of the major saturated fatty acids (SFAs), is a critical
metabolite that contributes to CKD-dependent vascular calcification. Mechanistically, CKD-mediated
hyperphosphatemia (high inorganic phosphate) induces the significant repression of VSMC stearoyl-CoA
desaturase (SCD), which is a major enzyme that controls levels of C18:0 by converting it to oleic acid (C18:1n-
9). Accumulation of C18:0 by SCD strongly induces severe lipotoxicity in VSMCs, resulting in vascular
calcification. In addition, our group has found that the pro-calcific effect of C18:0 is mediated by two major
metabolites of C18:0 generated via the enzyme reaction with glycerol-3-phosphate acyltransferase-4 (GPAT4):
1) 1,2-di-stearoyl-phosphatidic acid (18:0/18:0-PA), which induces vascular calcification through the activation
of the PERK-eIF2-ATF4 axis of the ER stress pathway and 2) 1-stearoyl-lysophoshatdic acid (18:0-LPA)
which strongly inhibits autophagic flux through the formation of abnormal MAM-associated omegasomes,
which are a platform for autophagosome formation. C18:0 induces vascular calcification through the activation
of the ER stress response and the inhibition of autophagy. However, the molecular mechanism underlying the
upstream event in which CKD-mediated hyperphosphatemia transcriptionally represses VSMC SCD has not
been studied. We believe that the identification of the mechanism has therapeutic potentials. To find clues of
the mechanism, we recently screened a library of chemicals that modulate epigenetics and gene transcription.
Based on the epigenetic and transcriptional chemical library screening, we identified two transcriptional
repressor candidates that contribute to phosphate-mediated SCD repression and vascular calcification. We
therefore propose two specific aims to elucidate the upstream event in the regulation of lipotoxicity-induced
vascular calcification. Aim 1 will examine whether the transcriptional repressor modulation complex affects
lipotoxicity and vascular calcification by altering SCD expression in cultured cells. Aim 2 will examine whether
modulation of transcriptional repressors affects phosphotoxicity, lipotoxicity and vascular calcification in vivo.
Completion of this project will provide a novel therapeutic target for CKD-mediated vascular calcification.

Public health relevance
Project Narrative Vascular calcification is a major cause of death in patients with chronic kidney disease (CKD) who have higher levels of serum phosphate and saturated fatty acids (SFAs). This research will find therapeutic targets for vascular calcification and enhance our understanding of the molecular mechanisms by which CKD promotes lipotoxicity and vascular calcification.